Characterization of a commensal enteric virus

SUMMARY
Crosstalk between immune cells and the epithelium protects the intestinal barrier from infectious and non-
infectious threats. Elucidating the signals that mediate this cellular crosstalk is necessary to improve our
understanding of diseases associated with barrier dysfunction, such as Crohn's disease (CD), a major type of
inflammatory bowel diseases (IBD). We previously established a model to investigate how a commensal and
otherwise beneficial virus induces immune-mediated damage in a genetically susceptibility host. Infection of
Atg16L1 mutant mice with murine norovirus (MNV) inhibits the function and viability of Paneth cells, antimicrobial
epithelial cells in the gut. Tissue sections and intestinal organoids derived from CD patients harboring the
ATG16L1 risk variant display similar Paneth cell defects. Thus, we have been using the MNV infection model to
examine how environmental factors cause epithelial defects associated with intestinal disease. In preliminary
data, we found that MNV inhibits secretion of a unique anti-inflammatory effector by T cells that we identified as
apoptosis inhibitor 5 (API5). Our data further suggest that API5 prevents inflammatory cell death (necroptosis)
of Paneth cells that are defective in the cell biological process of autophagy due to Atg16L1 mutation. The
objective of this proposal is to investigate the epithelial-intrinsic and -extrinsic mechanisms that underlie these
observations. We will determine how: (1) ATG16L1 and autophagy prevent necroptosis in the intestinal
epithelium, (2) API5 secretion by T cells is regulated in response to viral infection, and (3) extracellular API5
exerts protective functions. By investigating this virus-host susceptibility gene interaction, we anticipate
identifying new mechanisms involved in intercellular communication and epithelial resilience to injury, thereby
improving our understanding of immune-epithelial crosstalk during health and disease.

Public health relevance
PROJECT NARRATIVE A proper crosstalk between immune cells and barrier cells promotes gut health and prevents disease. We will investigate how a symbiotic virus disrupts this crosstalk in a genetically susceptible host to trigger damage that underlies the development of inflammatory bowel disease.